Inhibition of Human Islet Amyloid Polypeptide Aggregation

Abstract
Amyloid aggregation of islet amyloid polypeptide (IAPP) is associated with β-cell death in type-2 diabetes
(T2D). IAPP, a peptide hormone co-secreted with insulin by β-cells, is one of the most amyloidogenic proteins
and readily forms amyloid fibrils in vitro. Mounting evidence suggests that inhibition of IAPP aggregation and
aggregation-mediated cytotoxicity, our long-term goal, is an attractive therapeutic strategy to prevent β-cell
death and stop the progression of diabetic conditions in T2D. With the recent advances of Cryo-EM in
Structural Biology, atomic structures of IAPP fibrils have been solved, comprised of parallel in-register β-sheets
as the cross-β core. However, due to heterogeneous and transient nature of oligomer intermediates populated
during aggregation, many details of the process from isolated monomers to final fibrils are still unknown. With
amyloid toxicity likely mediated by direct or indirect interactions with the cell membrane, it is increasingly
important to study the aggregation of IAPP in the membrane environment. Increasing evidence also suggests
pathological correlations between different amyloid diseases – e.g., T2D is the risk factor of neurodegenerative
diseases, including Alzheimer’s and Parkinson’s diseases; and bacterial amyloids may contribute to the onset
of neurodegenerative diseases and diabetes. Cross-interactions between different amyloid proteins at the
molecular level might contribute to the pathological correlation between corresponding diseases. We have
demonstrated that novel nanoparticles can be engineered to mitigate hIAPP aggregation and cytotoxicity.
Despite many advantages including the ability to cross biological barriers, major concerns for nanomedicine
development include potential toxicity associated with immune responses and the lack of specificity. In this
MIRA renewal application, the PI proposes to continuously uncover molecular mechanisms of IAPP
aggregation and to explore novel nanoparticle approaches to inhibit IAPP aggregation and toxicity in the
following directions: 1) IAPP aggregation and interactions with the membrane; 2) cross-interactions between
hIAPP and other amyloidogenic proteins; and 3) mitigation of IAPP amyloidosis with nanoparticles
functionalized by endogenous inhibitors. The PI lab will combine computational modeling with experimental
characterization and validation. Computational modeling can help bridge the time and length scale gaps
between experimental observations and the underlying molecular systems, providing not only molecular
insights to experimental observations but also offering experimentally-testable hypotheses. Such a combined
computational and experimental approach can improve research efficiency and shorten discovery cycle. The
outcome of the proposed studies will help understand disease mechanisms and discover novel therapeutic
targets (Project 1); provide molecular bases for pathological correlations between T2D and other amyloid
diseases, and the contribution of bacterial infections and dysbiosis to the onset of T2D (Project 2); and offer
new approaches to design anti-amyloid nanoparticles with high specificity and reduced nanotoxicity (Project 3).
1

Public health relevance
Aggregation of human islet amyloid polypeptide (hIAPP) is associated with type-2 diabetes (T2D). We propose to uncover mechanisms of hIAPP aggregation and cross-interactions with other amyloid proteins, and design engineered nanoparticles to mitigate aggregation and the associated toxicity. Outcome of the proposed research will help better understand disease mechanisms of T2D and pathological correlations with other amyloid diseases, and aid in the design of anti-amyloid nanomedicine against T2D. 1